The Imprinted Gene Network in the Programming of Non-Alcoholic Fatty Liver Disease by Early Life Cadmium Exposure

Project summary
Non-alcoholic fatty liver disease (NAFLD) is characterized by fat accumulation, inflammation and tissue
damage in the liver. NAFLD affects 30-40 % of the US adult population, and patients with NAFLD have
a higher risk of developing liver cancer. An increasing body of evidence supports a role for the
developmental environment in the programming of NAFLD in later life. In support of this, we have
demonstrated that exposure to the toxic metal cadmium (Cd) during development causes NAFLD in
young mice. Cd is one of the top ten chemicals of major public health concern identified by the World
Health Organization, and it has been detected in newborn cord blood, suggesting that Cd exposure in
humans can begin during in utero development. In an effort to identify potential therapeutic targets that
could prevent the onset of NAFLD in response to developmental Cd exposure, we have studied the
underlying molecular mechanisms. We have identified the Imprinted Gene Network (IGN) as a novel
player in activating prosteatotic and profibrotic pathways – two of the major pathophysiological
processes that underlie NAFLD. However, it is unclear if this mechanism is specific to Cd or if it is
relevant to a broader set of toxicants that also program this disease. To address this, we propose three
specific aims: 1) perform a meta-analysis of hepatic transcriptome datasets from mouse models of
NAFLD programmed by the developmental environment to determine if the IGN is activated in response
to a diverse set of stressors; 2) screen toxicants for their ability to activate the IGN in a cell autonomous
manner in hepatocytes; 3) use in vitro models of toxicant exposure to test whether prosteatotic and/or
profibrotic mechanisms are dependent on the IGN. This work will considerably enhance the impact of
the parent award by demonstrating whether this mechanism is specific to Cd or also relevant to a
broader set of toxicants. This will be critical knowledge in the drive to identify druggable targets that
could be used to prevent the onset of NAFLD after early life exposures.

Public health relevance
Project narrative Non-alcoholic fatty liver disease (NAFLD) is a public health crisis, affecting 30-40 % of the US adult population. A mounting body of evidence supports a role for the early life environment in increasing susceptibility to this disease. The proposed work will identify previously unknown mechanisms through which exposure to toxicants during early life can increase the risk of NAFLD, providing the groundwork for the design of therapeutic strategies that could be used to prevent disease onset.